TASK ORDER NO.: 75N96024F00024 RESEARCH DEVELOPMENT - GENR METABOLOMICS STUDY DATA SUPPORT

NIEHS seeks to characterize longitudinal pathways of inflammation in pregnancy using metabolomics in order to examine patterns and associations with chemical exposures and childhood growth outcomes. The Generation R study is a unique prospective pregnancy cohort with rich existing information on prenatal non-persistent chemical exposures and long-term follow-up of children. Under this study, targeted and non-targeted metabolomics analysis of plasma samples will be collected and analyzed at early (<18 weeks gestation) and mid (18-25 weeks gestation) pregnancy as well as at delivery (cord blood plasma) among participants who have existing measures of prenatal chemical exposures as well as childhood follow-up to at least age 6.